Determining the role of Raftlin-2 in neural crest cell specification and migration

PROJECT SUMMARY
Cranial neural crest cells are a population of multipotent stem cells essential for craniofacial development
that contribute to the sensory ganglia and craniofacial skeleton. Neural crest cells are specified during
neurulation before undergoing an epithelial-to-mesenchymal transition (EMT) and migration; while we appreciate
the complex network of signaling pathways and transcription factors underlying specification and migration, the
regulation of these events remains incompletely understood. We have recently identified that expression of the
gene encoding Raftlin-2 is upregulated in neural crest cells during specification and maintained throughout
migration. Raftlin proteins localize to the plasma membrane where they are reported to organize lipid raft
domains and regulate diverse cell signaling events, leading us to hypothesize that Raftlin-2 contributes to the
development of neural crest cells through an impact on cell signaling. In preliminary studies probing Raftlin-2
function in the cranial neural crest of avian embryos using multiple knockdown strategies, we observed reduced
expression of several genes required for neural crest specification, suggesting that Raftlin-2 is essential for the
establishment of the neural crest domain. Aim 1 will investigate the role of Raftlin-2 in regulating specification by
using immunohistochemistry to measure neural crest specifier genes expression. Since specifier gene
expression is initiated by cell signaling pathways including Wnts and Bone Morphogenetic Proteins, I will next
use signaling activity-sensitive reporter constructs, and fluorescent in situ hybridization to investigate if Raftlin-2
regulates the activity of these pathways to govern specification. Finally, I will use RNA sequencing in Raftlin-2
deficient cranial neural crest cells to determine additional targets and signaling pathways dependent on Raftlin-
2 function. Our preliminary results also showed reduced neural crest migration area after Raftlin-2 knockdown
compared to controls in vivo, and we find that Raftlin-2 loss of function resulted in decreased migratory
persistence ex vivo, which led us to hypothesize that Raftlin-2 is necessary for effective neural crest migration
and adhesion after specification. Aim 2 will test this hypothesis using ex vivo explants to assay neural crest cell
directional migration and focal adhesion dynamics during chemotaxis. I will also use quantitative western blot
analysis to probe the activation states of molecular effector proteins downstream of chemotactic signals to define
and subsequently test the precise mechanisms of Raftlin-2 function during migration. Together these
experiments will uncover how Raftlin-2 impacts developmental signaling pathways necessary for cranial neural
crest cell specification and migration. These results will advance our understanding of how membrane
organization regulates craniofacial development insight and will provide novel insights that can be used to treat
craniofacial anomalies.

Public health relevance
PROJECT NARRATIVE Cranial neural crest cells are an embryonic population of multipotent cells that are essential for craniofacial development, giving rise to the craniofacial skeleton, neuronal and glial cells of the cranial ganglia, and melanocytes. Accordingly, disruption in their behavior results in congenital pathologies including Pierre Robin sequence, Treacher Collins syndrome, and cleft palate. By uncovering how Raftlin-2 organizes signaling events during cranial neural crest cell specification and migration, the proposed research will provide a foundation for understanding how these pathologies arise and to identify novel targets to develop strategies to treat and prevent a wide array of craniofacial defects.